MOTOR,NEUROPSYCHOLOGICAL &FUNCTIONAL CHANGES AFTER PALLIDOTOMY ON PARKINSON DIS

To study the effects of pallidotomy on motor and cognitive functions and on gait rhythmic motor functions as measured by specialized tests.